Administrative Core

CCSG ADMINISTRATION
ABSTRACT
The Roswell Park Comprehensive Cancer Center Administration provides the financial and administrative
resources, guidance, processes, and expertise to enable Roswell Park to achieve its mission to eliminate
cancer's grip on humanity by unlocking its secrets through personalized approaches and unleashing the healing
power of hope. Administration is led by Dale Henry, MBA, AD Administration and Judith Epstein, CCSG
Administrator, with 50 FTE staff from across the cancer center. Staff are responsible for programmatic initiatives,
shared resources and evaluation activities, ensuring appropriate infrastructure is in place for governance and
financial management. Administration coordinates membership and manages all research space and equipment
on campus, renovations and laboratory moves; interacts with marketing, philanthropy and information technology
to benefit faculty and staff. Oversight of the 17 CCSG and Institutionally-supported shared resources is done by
Administration team members. Communication initiatives include updating the web pages, funding and science
quarterly newsletters distributed to all CCSG members.
Administration successfully facilitated 162 new faculty recruits; establishment of the DEI initiatives (Change
Champions and implicit bias training); space and facilities management for the Community Outreach and
Engagement (COE) building and Cell Therapy Center; and integration of shared resources. Faculty Development
programs blossomed with Administration supporting the Cancer Research Training and Education Coordination
(CRTEC) team. The Plan to Enhance Diversity gained strength with CCSG Administrative support for meetings
and initiative implementation. Team science proposals involved planning and coordination across multiple
departments and institutions. Administration implemented EVAL to assist with CCSG membership and
publication management while also investing in InfoReady for internal pilot project application receipt and review
processes for philanthropic and CCSG Developmental Funds distribution.
Roswell Park finalized the strategic plan in 2023 focusing on five strategic objectives that include: (1) to advance
the future of patient centered care, (2) to maximize community impact, (3) to accelerate breakthrough
discoveries, (4) to foster a culture of diversity, equity, and inclusion, and (5) to enhance the education of faculty,
trainees and staff. In 2022-23, the internal strategic planning process led to the dissolution of the Genetics and
Genomics program and members redistributed to other programs. Future directions for CCSG Administration
include leadership development, ensuring continuity in CCSG knowledge, expansion of IT custom-built
applications including nSightTM, RevealTM and ImagineTM. Further, we are exploring new electronic research
administration systems to further enhance sponsored research fiscal management across the center.